Systems Immunology profiling of respiratory viral infections in vulnerable populations

SUMMARY/ABSTRACT
The Data Management and Analysis Core will provide data analysis and management services for the BRI
HIPC Center entitled “Systems immunology profiling of respiratory viral infections in vulnerable populations”.
This core will serve both Research Projects, receiving demographic and clinical data from the Clinical Core,
high quality ‘omics data from the Genomics Core, and high-dimensional cytometry from the Adaptive
Phenotyping Core. The Data Management and Analysis Core will ensure a unified approach to experimental
design and analysis for all projects and cores, be responsible for the flow of data and information across all
components of the Center, be responsible for the submission of completed data sets/projects to ImmPort, and
assist other Center members and Cores with submission to ImmuneSpace, GEO and other public archives. To
meet these goals, the DMAC will leverage existing infrastructure and expertise that exist at the Benaroya
Research Institute. The Data Management and Analysis Core has four Specific Aims, In Specific Aim 1, the
Data Management and Analysis Core will provide analysis services and consultation for all BRI HIPC projects.
In Specific Aim 2, the Data Management and Analysis Core will provide central storage, management and
information security for data generated by the BRI HIPC Center. In Specific Aim 3, the Data Management and
Analysis Core will integrate data management infrastructure with the Genomics, Adaptive Phenotyping, Clinical
and Administrative Cores. In Specific Aim 4, the Data Management and Analysis Core will coordinate the
timely submission of BRI HIPC data sets to ImmPort and other repositories, according to the NIAID standards,
and the data sharing plan. Data will be submitted in conformance with existing format standards and meta-data
annotation standards to facilitate integration with data from other HIPC investigators and with ImmPort tools for
data retrieval, visualization, and analysis. The key impactful features of the Data Management and Analysis
Core are the processing, tracking, and storage of HIPC Center data, the presentation of actionable information
in the process of completing both Research Projects, and the transformation of HIPC Center data into
information and interpretation via analysis.